Health, Aging and Dementia in South Africa: A Longitudinal Study (HAALSI)

Overall—Abstract
Adults in South Africa are surviving to older ages, yet the burden and risk factors of aging-related diseases,
particularly dementia and Alzheimer’s disease, remains poorly defined. By 2050, more than 75% of global
dementia cases are projected to occur in low- and middle-income countries (LMICs). The proposed renewal of
the Health, Aging and Dementia in South Africa: A Longitudinal Study (HAALSI) Program includes four
tightly integrated projects supported by three cores that together will reveal interrelationships among common
chronic diseases and other risk factors of cognitive impairment and dementia in South Africa. Each project
rests on a common platform of individual surveys, cognitive assessments, biomarker collection, and mortality
ascertainment, with additional measures specific to each project. In previous funding cycles (2014-2022), we
successfully collected three waves of HAALSI Agincourt data in 5059 men and women ≥40 years of age,
achieving response rates of 86-94% among living cohort members. We also collected two waves of data under
the Harmonized Cognitive Assessment Protocol (HCAP) at 3-year intervals. For this renewal application, the
HAALSI Program will continue following the HAALSI Agincourt cohort (Aim 1), including original enrollees and
a refresher sample of 1898, 40- to 49-year-olds, for a total of 13 years of longitudinal data. We will conduct a
third HCAP wave on a subsample of the HAALSI Agincourt cohort, with expanded biomarker, neuroimaging,
and clinical assessments to understand interactions among cognitive impairment/dementia, HIV infection, and
cardiometabolic disorders (CMDs). In Aim 2, we will identify biological, social, and economic predictors of
mortality and dementia, and assess disease incidence and changes in physical and cognitive function in the
HAALSI Agincourt cohort. In addition, in Aim 3, we will pilot and launch a nationally representative cohort study
of 4500 people ≥40 years of age and their partners (approximately 7200 total) using approaches from the
HAALSI Agincourt survey; of these, approximately 624 will also undergo the HCAP. The HAALSI National
survey will enable us to estimate the prevalence of dementia and other aging-related conditions, and their
cross-sectional associations with socioeconomic, behavioral, and health utilization exposures. We will use
innovative transportability methods to assess the alignment of diseases in the rural Agincourt community with
the national level. In Aim 4, we will evaluate the health impacts of public health and social policies developed to
improve healthy aging, specifically those aimed at reducing salt intake, and increasing financial security of
older adults, families, and individuals with disabilities. Finally, in Aim 5, we will maximize collaborations with
HRS sister studies, H3Africa and DS-I Africa projects, enabling cross-country comparisons and studies at the
level of population genetics. Together, the HAALSI Program will produce valuable insights into the burden and
drivers of dementia and other aging-related diseases in South Africa, which inform the development of effective
policies to ensure healthy aging and wellbeing of aging populations.

Public health relevance
Overall—Project Narrative Our proposed renewal, the Health, Aging and Dementia in South Africa: A Longitudinal Study (HAALSI) Program, aims to assess the biological, social, and economic factors and public policies that interact to influence the course of dementia and cognitive decline among older adults in South Africa, as well as major diseases and disorders (cardiometabolic disease and HIV) that impact cognitive function. We build upon our existing HAALSI cohort of older adults embedded within the well-characterized Health and Demographic Surveillance System (HDSS) of Agincourt, South Africa, which will provide 13 years of in-depth follow-up, establish a new nationally representative cohort, and conduct detailed dementia assessments within subsamples of each cohort using the Harmonized Cognitive Assessment Protocol (HCAP). We seek to implement approaches to the study of dementia and other health and aging related disorders that are valid, reliable, and harmonized with global studies of dementia and aging, in a country where little research has been done on a population basis.